SBIR Phase I - Topic 431 -A Fully Digital Volumetric Ultrasound Imaging and Therapy System for Low Resource Environments

Acoustiic will revolutionize cancer treatment in low resource settings by development of the first fully digital (no moving parts) system to image, target, and non-invasively destroy tumors with Volumetric High Intensity Focused Ultrasound (HIFU). The system will enable treatment in low resource environments due to its ease of use, low training requirements, compact nature for portability, relatively low cost compared to alternatives, ongoing monitoring during and post treatment, and the non-invasive aspect of the treatment. Moreover, it can be controlled remotely to target and treat tumors such as metastatic colorectal carcinoma allowing patients who live in rural remote settings to get effective treatment at home without frequent traveling to urban/metropolitan medical center.